Multimodal imaging of depression in Parkinson's disease

Abstract Treating depression in Parkinson’s disease (PD) effectively is a critically important unmet need. Depression affects almost half of those suffering from PD and significantly adds to the burden of the disease. Yet traditional antidepressants are inadequate in PD and identifying PD-specific treatment targets is vital. A loss of synapses is central to the pathology of PD, secondary to a toxic build-up of alpha-synuclein. Converging evidence suggests that synaptic loss contributes to depression also. Whether synaptic deficits play a distinct role in depression in PD, however, is unknown. Synaptic deficits and network abnormalities distinct to depression in PD could represent important new treatment targets. Using positron emission tomography (PET) we are now able to quantify synaptic density in-vivo. Our recently published work shows that a) there is almost 50% lower synaptic density in the substantia nigra in PD compared to healthy control (HC) subjects and that b) lower synaptic density is associated with higher severity depression, as well as network dysfunction, in individuals with major depressive disorder (MDD) and posttraumatic stress disorder (PTSD). We propose to quantify synaptic density (using PET) and network organization (using functional MRI) in PD depression for the first time. We will elucidate synaptic deficits and network abnormalities that are unique to depression in PD by imaging four groups of subjects: PD with depression, PD no depression, MDD no PD and HCs. We will use PET to determine whether synaptic deficits are distinct in PD depression by comparing synaptic density across PD, MDD and HC groups (aim 1). We hypothesize that synaptic loss will extend beyond the substantia nigra to prefrontal cortical and limbic regions related to mood regulation. We will also use fMRI to quantify the functional networks associated with depression in PD compared to other groups (aim 2). We hypothesize connectivity disturbances within and between substantia nigra and PFC/limbic networks, and that this will generalize to an independent, publicly available dataset. We will then integrate these aims and combine PET and fMRI data to determine whether depression- associated brain networks are underpinned by distinct patterns of synaptic loss in PD (aim 3). We hypothesize that synaptic deficits in substantia nigra, PFC and limbic regions will be associated with widespread connectivity disturbances in PD depression. Findings could implicate a pattern of synaptic deficit/network dysfunction distinct to depression in PD that could be targetable with synaptic-enhancing and network-reorganizing interventions such as ketamine and neurofeedback, and therefore have a direct translational impact on the effective alleviation of depression in PD.

Public health relevance
Project Narrative Depression affects approximately half of those suffering from Parkinson’s disease (PD) and is associated with reduced quality of life, increased disability and a faster rate of progression. However, traditional antidepressants are inadequate and novel mechanistic research is needed to identify new treatment targets that are specific to depression in PD. Using an innovative approach, we will combine PET and MR imaging to identify the synaptic deficits and resultant network alterations that are distinct to depression in PD, which can then be targeted with novel synaptic-enhancing interventions such as ketamine.